HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS)

The HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS) consists of five distinct
NEST Projects responsible for development of the implantable pulse generator (IPG), external charger and
controller (NEST 1-2), and selection of interoperable and implantable leads for stimulation and sensing (NEST
3-5). The final goal is to realize a fully functional integrated system with interoperable leads that will be
community-supported technology platform. The Technology Integration and Dissemination (TID) Core will
support this goal by facilitating the interconnection between the NEST Projects to realize a logical integration
plan. NEST 1-2 and NEST 3-5 will run in parallel and achieve module level testing before beginning system
integration. Then NEST 1-2 will result in a fully integrated IPG with external charger and controller. Final
integration will involve testing different leads and lead configurations with the IPG system.
The TID Core will also spearhead the Center’s multi-pronged approach to achieve broad dissemination of
CARSS technology. The Center will also employ a collaborative approach, working with other HORNET Centers
to facilitate dissemination.
CARSS will share content different venues and formats including a newsletter, social media posts (LinkedIn),
articles (include special issue contributions), reports, presentations (at meetings, conferences, and seminars),
short courses (including recorded and downloadable training modules and tutorials), and on-site training events.
The Center will maintain a website, wiki, and online repositories, each providing access to different types of users
and addressing different user needs. CARSS will also coordinate with the SPARC Data and Resource Center
to share developed materials. The open-source license strategy will allow open collaboration, facilitating
derivative hardware and software products.

Public health relevance
Not applicable per solicitation. Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRAsystems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.